Clinical evaluation and development of a diagnostic multi-modal intravascular imaging system

? DESCRIPTION (provided by applicant): Understanding that not a single imaging technique can alone address needs of all vascular diagnosis, OCT medical imaging Inc. (OCTMI) propose to develop a clinical multimodal intravascular imaging system encompassing ultra-high resolution optical coherence tomography(OCT) and IVUS. This Combined multimodal vascular imaging system will permit cross-sectional visualization of vascular artery with unprecedented resolution and depth not possible with any of these technologies alone. This multi-modal imaging strategy in a single system permits use of a single disposable guide wire, thereby reducing cost to hospital, patients and improving prognosis by early detection. We believe these technologies together will provide 1) critical 3D and cross-sectional details & functional information necessary for identifying vulnerable plaques 2) inside-out view of vessel necessary for stent sizing 3) extent of mal-apposition of stent struts in artery 4) extent of post-stent thrombosis. In a multi-institutional effort, we plan to create this multi-modal probe and necessary hardware in Phase I, followed by extensive clinical trials in phase II before seeking FDA approval and marketing in Phase III

Public health relevance
PUBLIC HEALTH RELEVANCE: OCTMI is seeking funds that will directly contribute to the easy advanced detection and diagnosis of heart disease that affects human in every part of the globe. We are seeking funds to develop an advanced functional OCT system that will help reduce mortality, minimize number of invasive biopsies and dramatically improve the clinical outcome, while reducing cost and time required for diagnosis. Proposed module based system is a unique combination of the most advanced Ultrasound & Optical Coherence Tomography technologies, will likely change the diagnosis landscape of cardiovascular disease and outcome. OCTMI has licensed OCT, technology from University of California, Irvine. Researchers who participated in system development are either co-founders of OCTMI or collaborating in this project. We are collaborating with Univ. of Southern California; a leading center in Ultrasound will be our partners in this effort. This multi-institution effort, involving OCTMI, USC and researchers from UCI will ensure the success of this project. Technology which was developed in the laboratory is now being transferred to market place through OCTMI.